Mechanisms and Genetic Consequences of Break-Induced Replication.

PROJECT SUMMARY
During normal cell metabolism, exogenous and endogenous factors cause double-strand DNA breaks
(DSBs) that result in genome instability. DSB repair is critical for cell viability, but some DSB repair
processes exacerbate genome instability. Break-induced replication (BIR) is a unique DSB repair
mechanism associated with telomerase-independent telomere maintenance and genome instability.
Although BIR is evolutionarily conserved from phages to mammals, BIR in mammals has only recently
gained attention. Because BIR involves non-reciprocal copying of the template through conservative
DNA synthesis, errors in this process occur and can lead to catastrophic genome instability in the form
of genomic duplications, translocations, and rearrangements. BIR, which is less frequent than other
DNA repair mechanisms, is context-specific. Because its role in mammalian cells was only recently
discovered, and BIR has often been overlooked in favor of more common DNA repair mechanisms,
here we argue that an in-depth study of BIR mechanisms is needed.
My long-term goal is to understand the role of BIR in promoting genome instability and
maintaining telomere lengths. To understand the mechanisms and genetic consequences of BIR, I
will take a multidisciplinary approach that combines cell biology, biochemistry, and genomics. My goals
for the next 5 years are (1) to determine the mechanisms by which BIR is regulated at telomeres
and transcriptionally active loci in the genome and (2) to develop new experimental tools and
techniques for studying BIR. Collectively, the proposed projects will elucidate the connection
between BIR, genome instability, and telomere elongation. Further, we will identify the upstream
regulatory mechanisms that initiate BIR coupled with transcription. Ultimately, these studies will
advance our understanding of the relationship between transcription and genome instability.

Public health relevance
PROJECT NARRATIVE Break-induced replication (BIR) is a unique DNA repair mechanism associated with telomerase- independent telomere maintenance and genome instability. In this MIRA R35 proposal, we will elucidate the mechanisms that promote BIR in the genome and at telomeres to better understand the relationship between transcription and genome instability.